Retinoblastoma Phase II Expanded Access Clinical Trial

Abstract
Retinoblastoma (RB) is a micro-orphan disease intraocular cancer in infants and children (typically diagnosed
between birth and 5 years of age). Approximately 250 new cases are diagnosed annually in the United States.
Standard of care for retinoblastoma includes removing the affected eye (safest) or attempted salvage of the eye
starting with systemic or intra-arterial chemotherapy. Since external beam radiotherapy incurs life-long high risk of
second cancers in RB H1 patients carrying the RB1 cancer predisposition gene, it is reserved for last effort to save
a last eye. There is no FDA approved intervention for retinoblastoma. Topotecan Chemoplaque (IND #112785) as
a single (one) treatment achieves sustained local six-week delivery of Topotecan directly to the interior of the eye
while sequestering Topotecan from washout to peripheral circulation. The RP2D was determined to be 2 doses: 0.9
mg (single Chemoplaque) or 1.2 mg (two 0.6 mg Chemoplaques), depending on patient age and tumor features.
Sustained CR (absence of Standard of Care therapies after the Chemoplaque) was achieved in 10/12, 0.9 mg,
83% and 8/9, 1.2 mg, 89% evaluable for efficacy.
In the 1.2 mg dose that we plan to progress in the proposed trial, the sustained CR rate is 89%. All the CRs are
out > 2 years. All the CRs were in refractory settings, including refractory solid tumor, refractory vitreous seeds,
and refractory subretinal seeds. At the RP2D based on swimmer plot analysis, for patients that were refractory to
IAC, treatments before and after Chemoplaque are as follows:
As such, the Chemoplaque significantly reduces subsequent treatment burden in patients refractory to IAC.
Toxicity analysis includes 22 participants treated at the RPD2 (12, 0.9 mg /10, 1.2 mg).
No systemic toxicity was observed. At all time points, plasma Topotecan levels were below limits of detection
except one trace (<1 ng/ml detection only on day 1 in the smallest child). Vitritis/scleritis developed in 2
participants after 4 weeks (1/12 at 0.9 dose, and 1/10 at 1.2 dose), which responded to local steroids with resulting
sustained CRs (now out > 2 years). All eyes have a full thickness chorio-retinal scar directly opposite the
Chemoplaque. All participants reported signs of inflammation and reduced well-being, similar to babies teething
that resolves in all cases following Chemoplaque removal and (if applied) is responsive to local steroids. The
Phase I Trial RP2D analysis suggests that Topotecan Chemoplaque has good, sustained effectiveness in refractory
settings including refractory solid tumor, refractory vitreous and subretinal seeds—given as a single application
(one treatment) without need for repeat treatment or multiple cycles. To our knowledge, there are no
retinoblastoma interventions that are effective (result in CRs) after a single application, and further, there are none
that are effective across all lesion types let alone as a single application. The chemoplaque has demonstrated
robust activity across all lesions as a one-time treatment with no systemic toxicity.
This FDA Orphan Drug Grant application requests support for Expansion Phase II clinical trial of Topotecan
Chemoplaque at the 1.2 mg RP2D dose. EUAs will follow standard of care at 0, 4, 8 and 12 weeks. In the
proposed study, we will enhance study of impact beyond Progression-free Survival by quantitating invasiveness of
subsequent therapies, extending the Swimmer RB analysis. The Topotecan Chemoplaque has potential to be the
first FDA-approved therapy for this micro-orphan childhood disease and offer simple treatment—important in low
resource settings where the majority of RB children live.
The efficacy and safety of the RP2D (1.2 mg) Chemoplaque in refractory disease addresses a critical need
(provides an alternative to radiation and life-long increased risk of secondary cancers) providing an important
addition to the armamentarium of RB interventions.

Public health relevance
Project Narrative: This application requests funds to support the efforts of Targeted Therapy Technologies, LLC (3T) to build on the strong preliminary results of Episcleral Topotecan (Chemoplaque) Phase I studies treating eyes with refractory retinoblastoma, indicating 89% sustained Complete Response (all CRs out > 2 years) with the RP2D (1.2 mg) with the only toxicity being ocular inflammation (scleritis) that resolves after removal. Further, there was no systemic toxicity or detectable exposure in blood. In the refractory setting, as a single treatment (no cycles or multiple treatments) the Chemoplaque treated refractory solid tumor, vitreous and subretinal seeds. We are unaware of other interventions that can robustly treat all three lesions—let alone as a single treatment in a refractory setting. We propose a Phase I-II study to expand toxicity and effectiveness data of Episcleral Topotecan (Chemoplaque). In this study, EUAs will be at 0, 4, 8, and 12 weeks (see protocol in appendix) reducing the frequency to standard of care as efficacy and safety have been established. Assessment of retinoblastoma tumor burden is problematic. Unlike other cancers, both eyes of the child may have multiple tumors, with multiple primary treatment options and multiple subsequent treatments, challenging the difficulties of Response Evaluation Criteria In Solid Tumors (RECIST).1 Rather than tumor size, retinoblastoma cancer activity is best evaluated by experts using many tools. We built for the first Topotecan Chemoplaque study, the SWIMMERRB display of all therapies to a study eye before and after the Topotecan Chemoplaque intervention, which visually shows Progression-free Survival and details the multiple treatments before the intervention and after for recurrences. We consider any cancer therapy to the study eye after removal of Topotecan Chemoplaque to be evidence of recurrence. Through consensus building conferences primarily with patients and those with lived experience in retinoblastoma, we will seek numerical values to represent invasiveness/lifelong impact of each therapy. Application of the values to the various Topotecan Chemoplaque study long term outcomes, may validate the SWIMMERRB as a unique RECIST tool1. Such a SWIMMERRB tool may enable retinoblastoma clinical trials to have a standardized, validated output and assist families in treatment choices. The Chemoplaque in refractory settings required single (one) placement with sustained 6-week treatment (without need for multiple cycles or multiple treatments) treating refractory solid tumor, subretinal, and vitreous seeds with potential to significantly reduce patient burden in this micro-orphan childhood retinoblastoma cancer. With its simple placement and absence of any systemic toxicity (or detectable exposure in blood), this may be especially relevant in developing countries. 1. Berry JL, Munier FL, Gallie BL, et al. Response criteria for intraocular retinoblastoma: RB-RECIST. Pediatr Blood Cancer. May 2021;68(5):e28964. doi:10.1002/pbc.28964 Project Narrat